Structural Biology

ABSTRACT
The goal of Structural Biology (SB) Core (formerly X-Ray Crystallography Core) is to provide access
to expertise as well as state-of-the-art equipment and software to Center laboratories that address
structural questions within their research. Understanding the biological processes involved in
tumorigenesis has increasingly benefitted from structural investigations that provide key functional and
mechanistic insights, as well as atomic-level details important for drug discovery. Many of the
questions require the structure determination of large proteins, assemblies and macromolecular
machines. The Core maintains in house equipment (Rigaku Micromax 007hf diffractometer and Titan
Krios-Gatan K2 cryo electron microscope) and computational resources for data collection, processing
and structure determination, including graphical workstations and a high-performance Linux cluster. The SB
Core implements a range of software packages for structural determination and analysis, participates in
multi-institutional consortia for access to synchrotron beamlines and cryoEM and provides training and
assistance to users. In addition, the Core Head collaborates with non-structural MSK groups on
macromolecular crystallization and structure-determination projects, and also provides modeling expertise
and guidance to those labs that can benefit from the use of available structures in the design and
interpretation of experiments.